Molecular and cell biological basis of convergent extension

Abstract
Collective cell movements termed convergent extension (CE) drive the elongation of tissues and organs in
essentially all animals. In vertebrates, CE is controlled by the planar cell polarity (PCP) signaling system, and
defects in PCP-dependent convergent extension are associated with human neural tube defects and skeletal
dysplasias. We feel that the overall lack of clarity regarding upstream inputs that guide CE as it occurs in
vertebrate animals represents the key challenge in the field at this time. Building on our recent successes with
in vivo imaging, in vitro assays of mechanosensing, structure modeling, and genomics, this proposal takes a
holistic approach to this problem, focusing on both mechanical and molecular inputs and how they direct the
action of PCP proteins, actomyosin and cadherin adhesion during CE.

Public health relevance
Project Narrative: This study centers cell movements called convergent extension which are controlled by a set of proteins called the planar cell polarity (PCP) proteins. These experiments will be significant because convergent extension is essential for neural tube closure and limb morphogenesis, and failure of these movements results in human birth defects such as neural tube defects and skeletal dysplasia. Thus, experiments proposed here will shed new light on mechanisms underlying human congenital anomalies.